STD and AIDS Research Training Grant

ABSTRACT
The University of Washington provides a rich and stimulating environment for the STD & AIDS Research, with
Federal and foundation funding for STD & AIDS-related research, training, and service at UW and its affiliated
institutions exceeding $550 million. The number of UW faculty involved in STD and HIV/AIDS research has
grown from 10 in 1970 to over 700. This STD & AIDS Training Program, now in Year 45, has trained 250
trainees (73 pre- and 177 post-doctoral). Of all fellows and students who have completed training, 80% hold
faculty or senior research positions in academia, leadership positions in public health or government, or senior
scientist positions in the biomedical sciences. For the current proposal, Anna Wald MD, MPH will continue to
serve as Program Director, with Julie Dombrowski, MD, MPH and Lorenzo Giacani, PhD serving as Co-
Directors. The Executive Committee (Dombrowski, Giacani, Hybiske, John-Stewart, Koelle, Manhart,
McClelland, Wald) will also provide oversight of the program, help to monitor trainee progress, evaluate and
select applicants, and discuss potential new initiatives and developments in STD & AIDS research. A carefully
selected group of 71 faculty will serve as Senior or Junior Mentors. We request continued funding for 5 post-
doctoral (1 PhD and 4 MDs) and 5 predoctoral trainees. The Program’s Core Curriculum, mandatory for all
trainees, includes the following annual events:
• Principles of STD and AIDS Research, a 2 week intensive course on research questions and methods
• STD & AIDS Research Symposium, held in Fall, with presentations by trainees and new investigators
• STD & HIV Winter Dinner, with a special guest speaker
• STD and HIV Training Retreat, to be held annually each Spring
• Biomedical Research Integrity series
• Survival and Thriving in the Research Years
• Focused research conferences, seminars, and symposia relevant to trainees’ area of research
• Didactic training related to Rigor and Reproducibility
• MD trainees will receive clinical training experience in STD, HIV/AIDS, and HIV/viral hepatitis clinics.
Research training has been re-organized into three tracks representing research from the Molecular and
Cellular level (Host-Pathogen) through the Individual level (Clinical & Behavioral) to the Societal level
(Population Health), all offering pre- and postdoctoral training (including MPH or MS in epidemiology options
for MD trainees). Trainees will have mentoring committees and will use Individual Development Plans to
guide their career development. The program evaluation plan includes process and outcome objectives,
with systematic collection of these measures with ongoing program modification as indicated.

Public health relevance
PROJECT NARRATIVE Sexually transmitted infections, including HIV, are major public health issues in the United States and globally. This training program, now in its 45th year, has trained 250 predoctoral students and postdoctoral fellows, including infectious disease physicians, in STD and HIV/AIDS research, 80% of whom have continued in academia, public health or government, or in other biomedical research venues. Continued support for this training program is requested.